Molecular mechanisms for clinical dominance of P. aeruginosa ST111 isolates

PROJECT SUMMARY
Pseudomonas aeruginosa is an opportunistic human pathogen rated as a “serious threat” by the Centers for
Disease Control and Prevention. It is particularly dangerous to immunocompromised patients, including patients
with hematologic malignancies (HM) and those recovering from hematopoietic stem cell transplantation (HCT).
Recent epidemiological study discovered that fluoroquinolone (FQ) neutropenic prophylaxis in HM/HCT patients
was associated with breakthrough bloodstream infections with P. aeruginosa. These bloodstream infections were
dominated by isolates from the ST111 multilocus sequence type, a group of high-risk P. aeruginosa clones
known to frequently cause outbreaks of multidrug or extremely drug resistant infections in healthcare settings,
including HCT units. Our prior studies demonstrated that the vast majority of ST111 isolates from HM/HCT pa-
tients at Oregon Health Sciences University undergoing FQ prophylaxis were non-susceptible to both FQ and
meropenem, despite only a small fraction (5%) of patients receiving meropenem in the previous 6 months. Car-
bapenems are a crucial, front-line therapy in this patient population, and non-susceptibility is associated with
substantial increases in morbidity and mortality. Despite this, a knowledge gap remains in the mecha-
nistic understanding of the factors that contribute to ST111 dominance.
Our preliminary data indicated that at least two different factors may drive this dominance. First, we have
evidence that ST111 secretes an inhibitory protein complex that prevents the growth of some other strains of P.
aeruginosa. This allows ST111 strains to dominate other strains, despite growing worse in isolation. Our prelim-
inary studies have identified this factor and pinpointed a defense mechanism used by resistant P. aeruginosa
strains to overcome growth inhibition.
Second, whole genome sequencing has demonstrated that all of the dominant ST111 isolates have disrup-
tions to the quorum sensing regulator lasR. These quorum sensing mutants are predicted to be able to utilize
the normal signaling pathways, but do not expend the resources to contribute to them (a phenomenon often
observed in quorum sensing mutants). Importantly, some of the ST111 isolates had a fitness advantage com-
pared to PA14ΔlasR, while others did not, suggesting that these factors may be additive.
In this grant, we propose to study each of these mechanisms and estimate their impact in a wider panel of
ST111 and sensitive isolates. Genetic and cell biological tools we have generated will be used to study each of
these factors, including previously unrecognized players in the production of the inhibitory factor. We will also
study LasR and its downstream components to determine what role they play in ST111 dominance. Completion
of the proposed experiments will help confirm factors that drive the dominance of ST111 and may help identify
methods to limit this dominance so that the spread of ST111 can be reduced, significantly improving clinical
outcomes for HM/HCT patients.

Public health relevance
PROJECT NARRATIVE Pseudomonas aeruginosa causes serious and frequently fatal hospital-acquired infections, particularly in neutropenic patients like those with hematologic malignancies or who are undergoing hematopoietic cell transplantation. High-risk strains, such as ST111, which are associated with increased virulence and antimicrobial resistance, tend to be clinically dominant in these populations, although the causes have remained unclear. Our preliminary data indicate that the dominance of ST111 is driven by two factors which this grant will study: suppression of other P. aeruginosa sequence types by a secreted protein complex and by exploiting quorum-sensing signals secreted by other bacteria.